Alcohol Biomarkers In Post Liver Transplant Patients

DESCRIPTION (provided by applicant): The goal of this mid-career K24 application is to support the mentoring and research activities of Dr. Michael Fleming. He is committed to continuing an active research program in clinical and translational research. This grant is a competitive renewal that was initially funded in September 2005 and will end in September 2010. He is asking for an additional 5 years of funding. Dr. Fleming successfully completed the two research studies proposed in the initial application, participated in training activities and mentored PhD students, post doctoral fellows and faculty. During the period of the award he was elected to the National Academy of Sciences Institute of Medicine for his alcohol research and mentoring. He is also a national leader among the CTSA (Clinical Translational Science Award) programs and is the chair elect of the national CTSA Education Key Function Committee and Mentor Working Group. Work completed with current K24 grant: The first study evaluated two alcohol biomarkers, Blood Alcohol Levels and Carbohydrate-Deficient Transferrin (CDT), in a sample 214 patients admitted for trauma. The second study tested the efficacy of methylphenidate in a sample 13 children with a diagnosis of Attention Deficit Disorder and Fetal Alcohol Spectrum Disorder. Since 2005 his research group and trainees have published 42 research papers in the substance abuse area. Co-authors of these papers include five students, nine physician post doctoral research fellows, 11 University of Wisconsin-Madison physician faculty and scientists from 12 non-UW research groups. Over the last four years six of his trainees have been awarded K23/K08/K12/K01/R21/R03 grants, one MD PhD student was awarded an F30 and another PhD student an F31 grant. Without the salary and research support provided by the K24 grant much of this work and the success of his trainees would not have been possible. Proposed work for the K24 renewal: The K24 renewal will provide protected time for Dr. Fleming to mentor seven assistant professors in the departments of medicine, pediatrics and family medicine and facilitate his ability to write papers with trainees from three recently completed R01's. He will also initiate a prospective alcohol biomarker study that will test the predictive validity and reliability of Phosphatidylethanol (PEth) and CDT in a sample of 250 post liver transplant patients. Subjects will be recruited from four transplant centers. The biomarkers will be compared to patient self-report, family member interview and transplant staff concerns as well as medical records data. PEth and CDT will be measured at six-month intervals for one year. Significance: The K24 is critical for Dr. Fleming's continued ability to mentor new investigators in alcohol research and for his research on alcohol biomarkers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of the study is to find out if a lab test can tell which patients are drinking alcohol after having a liver transplant. A positive study would help physicians identify and treat patients before they damage their new liver. 7. Project Narrative - The goal of the study is to find out if a lab test can tell which patients are drinking alcohol after having a liver transplant. A positive study would help physicians identify and treat patients before they damage their new liver. __SpecificAimsTextDelimiter__ 10. Specific Aims - The goal of the proposed research study is to compare the predictive validity of Phosphatidylethanol (PEth) and Carbohydrate Deficient Transferrin (CDT), in detecting alcohol use, in patients who received a liver transplant for alcohol related liver disease. These markers will be measured at baseline, six months and 12 months. The levels of these biomarkers will be compared to patient self- reported alcohol use, family member corroboration and transplant team concerns. Participating transplant centers will include the UW Madison, Northwestern, University of Minnesota and the Medical University of South Carolina. Power estimates suggest 200 transplant subjects will provide an 80-85% chance of detecting a difference in the "area under the ROC (Receiver Operating Curve) curve" between PEth and CDT. A control group of abstinent post transplant patients, with no history of alcohol related liver disease or alcohol abuse/dependence (n=50), will be included to assess the frequency of false positive tests. Alcoholic liver disease (ALD) is the second most common indication for liver transplant in the United States and in Europe. The 'Organ Procurement and Transplantation Network' reported 6,319 liver transplants were performed during 2008 with 16,593 patients on waiting lists40. The frequency of alcohol related liver disease varies by center but ranges from 15-40%. There is increasing evidence that alcohol use post transplant is an important risk factor for liver injury and hepatic failure. Early detection of alcohol use, prior to liver injury, is a priority for transplant programs. Detecting alcohol use, however, in post transplant period is difficult. Denial, shame, family issues and fear of the consequences complicate patient self report. Biomarkers such as PEth, CDT, EtG, FAEE could provide additional information in the detection and monitoring of alcohol use. Early detection is important if counseling, anti craving drugs, and support from family members and the transplant team are to prevent injury to the transplanted liver. The study will include patients who received a liver transplant for alcohol or combined alcohol/hep C infection after January 1, 2003. Studies suggest increasing risk of relapse over time. PEth and CDT will be measured at six month intervals (baseline, 6 and 12 months) on all subjects. In addition all patients with a positive PEth or CDT will have the test repeated 10-14 days after the initial positive test. The PEth test is performed on whole blood using an HPLC assay by a specialty lab in Chicago. The CDT test will be performed by Dr. Raymond Anton's lab in Charleston using an HPLC assay. We have elected not to test the performance of other markers such at EtG or FAEE due to cost considerations and recent reports questioning the usefulness of these markers in general medical/surgical settings. Strengths of the study include an adequately powered sample, a prospective design, HPLC assays for PEth and CDT, multisite patient recruitment, confirmation of patient self report by family members and transplant staff,an experienced PI, a strong research team, and an outstanding external advisory panel. The primary aim of this study is to compare the Receiver Operating Curves of PEth and CDT using three different levels of alcohol use - any drinking in the past 30 days, heavy episodic drinking (>60 grams of alcohol on eight or more occasions in the previous 30 days), and >40grams of alcohol per day in the previous 30 days. Secondary aims of the study are to determine: 1) the test retest reliability of PEth levels; 2) the frequency of an elevated PEth, CDT, and alcohol use by number of years post transplant; 3) the correlation of PEth, CDT and alcohol use with post transplant complications such as liver injury, infection, rejection, hospitalization; 4) predictors of relapse in the post transplant period.